Plasminogen in glomerular disease progression

Project Summary
Despite significant evidence identifying the podocyte as the key glomerular cell target for injury, validated
therapeutic targets are scarce and commercially available cell-specific therapy is lacking. Additionally, given the
heterogeneous nature of proteinuric kidney disease, biomarkers to identify patients at high versus low risk for
progression to end-stage kidney disease (ESKD) are needed. Our long-term goal is to identify key regulatory
pathways and therapeutic targets in the treatment of proteinuric kidney disease. We previously identified the
serine protease plasminogen as a mediator of direct podocyte injury and a potential targetable urinary biomarker
that correlates with albuminuria, edema and renal function. Recently, we developed a de novo electro-
chemiluminescent immunoassay (ECLIA) to accurately measure urinary plasminogen and demonstrated its
utility in predicting ESKD progression in a large, diverse patient cohort. The overall objective of this application
is to define the role of plasminogen as a mediator of podocyte injury and a potential therapeutic target in
progressive glomerular disease. Our hypothesis is that under normal conditions with an intact glomerular filtration
barrier, podocytes are not exposed to plasminogen. In proteinuric disease, plasminogen induces podocyte injury,
with plasminogenuria serving as a targetable biomarker. Amiloride (and 6-substituted hexamethylene amiloride)
derivatives could have podocyte protective properties by inhibiting urokinase plasminogen activator (uPA), the
serine protease that specifically cleaves the proenzyme/zymogen plasminogen to form the active plasmin. Our
hypothesis will be tested by pursuing two specific aims: Aim 1 will define the role of plasminogen in podocyte
injury and glomerular disease. We will develop a podocyte-specific plasminogen-targeted network controlling
podocyte focal adhesion dynamics, define the in vivo molecular mechanisms linking plasminogenuria to
podocyte injury, and test the molecular interaction between plasminogen and LIM-nebulette in regulating
podocyte structural integrity. In Aim 2, we will define plasminogen as a targetable biomarker in proteinuric kidney
disease. We will define the association between baseline urinary plasminogen and longitudinal outcomes in a
general CKD cohort as well as patients with glomerular disease. We will use rational design and medicinal
chemistry to optimize plasminogen inhibitors for podocyte protection. Additionally, we will also test the efficacy
of novel plasminogen inhibitors in experimental glomerular disease. The work proposed is expected to
characterize the role of plasminogen in podocyte injury and glomerular disease progression. If successful, the
results could define plasminogen as a targetable biomarker in the treatment of proteinuric kidney disease.

Public health relevance
Project Narrative Plasminogen can act as a “second hit” in glomerular disease by inducing direct podocyte injury. Plasminogenuria correlates with proteinuria and kidney function decline in human glomerular disease. The proposed research will characterize the role of plasminogen in podocyte injury and glomerular disease progression and potentially define plasminogen as a targetable biomarker in the development of novel therapeutic strategies for proteinuric kidney disease.